Iowa-Wide Oncology Research Coalition (I-WORC)

Project Summary/Abstract
The Iowa-Wide Oncology Research Coalition (I-WORC) is a multidisciplinary consortium of
nineteen components and six sub-component performance sites comprised of twelve hospitals,
including one designated children’s hospital, nine gynecologic, medical, pediatric, radiation, and
surgical oncology practices and sixty-five physician investigators. In addition to the operations
office in Des Moines, the I-WORC has component sites located in four geographical regions in
Iowa (Ames, Cedar Rapids, Mason City and Ottumwa/Fairfield) and one geographical region in
Moline, Illinois. I-WORC is an original NCI Community Oncology Research Program (NCORP)
Community Site and has affiliations with the following research bases: Alliance, ECOG-ACRIN,
NRG, Wake Forest, and COG. I-WORC also actively participates in other non-member research
base studies through the Cancer Trials Support Unit (CTSU) and has experience using the
Central Investigational Review Board (CIRB) for human subjects review.
The goals of I-WORC are: 1) Provide excellence in cancer care to patients and families through
participation in high quality cancer research studies including control, prevention, treatment and
care delivery; 2) Support the goals and work of research bases with involvement of I-WORC
investigators and research staff to provide insight into clinical significance and feasibility during
concept and protocol development, as well as identification of unique patient populations; 3)
Increase public and professional awareness of clinical trials through community outreach efforts
and collaboration with other medical providers in the community; 4) Increase accrual in clinical
studies by building on prior recruitment strategies implemented in previous cancer
control/cancer prevention, precision medicine, and treatment studies; 5) Develop strategies to
increase clinical trial participation in racial/ethnic minorities, adolescent and young adult (AYA)
and elderly, sexual and gender minorities, and the underserved population in rural areas; 6)
Collaborate with local health care institutions to increase participation in correlative and
translational bio-specimen collection studies; 7) Collaborate with local health care institutions to
continue to develop and expand participation in cancer care delivery studies; 8) Capture and
document screening efforts for clinical trial enrollment and address cancer health disparities by
building on prior screening log strategies.

Public health relevance
Project Narrative The I-WORC NCORP has a proven track record as an efficient and disciplined team from six strategically located Iowa and Illinois communities. The coalition serves as the link between NCI-approved cancer research and over two million people in the state of Iowa and the eastern portion of Illinois with a history of achieving results in clinical cancer research while being a leader both locally and in nationwide cooperative groups. The I-WORC NCORP fosters quality in its research efforts and collaboration with local resources to promote clinical trial participation, bio-specimen collection, and cancer care delivery research.